Synoviocyte endothelial cell cross talk in rheumatoid arthritis

ABSTRACT
The management of rheumatoid arthritis (RA) has been transformed by immune targeted disease-modifying anti-
rheumatic agents such as tumor necrosis factor alpha inhibitors. However, an unmet need persists for therapies
that would be more tailored against local and disease-specific mechanisms and thus be less
immunosuppressive. The application of genomic approaches to the study of cells and tissues from patient
synovium has recently allowed scientists to focus on the complex relationship between different cell types and
between cells and matrix in RA synovium. This brough a renewed attention to the role of stromal joint cells such
as fibroblast like synoviocytes (FLS) and blood vessel endothelial cells (EC). It has been recently observed that
cells similar to FLS are found in the circulation of patients with RA suggesting that FLS can egress the synovium
through blood vessels. However, transvascular FLS migration has not been reported in RA and its mechanisms
remain unknown.
We have collected initial evidence of FLS transmigration through EC layers in the synovium of RA patients and
a mouse model of RA and have data suggesting that vascular FLS transmigration promotes vascular permeability
in vivo. We also have developed an in vitro system to study RA FLS-EC transmigration process and collected
evidence that transmigration of FLS alters the phenotype of EC. Finally, we have identified a gene that selectively
controls the transmigration of RA FLS through EC layers. The aims of this grant are to validate a pathway that
we believe connects FLS transmigration with EC-mediated inflammation using RA synovial specimens, in vitro
and in vivo models (Aim 1), and assess whether the FLS gene that we have discovered influences FLS
transmigration and arthritis severity (Aim 2).

Public health relevance
NARRATIVE We have discovered a new process of cross talk between two non-immune cell types called synoviocytes and endothelial cells which we believe contributes to promote inflammation in the joints of patients with rheumatoid arthritis (RA). The objective of this project is to demonstrate that this process is ongoing in human RA joints and mouse models of disease. The long-term goal is to design novel therapeutics against this mechanism to help control RA.